Amadorins for Ameliorating Alzheimer's Disease and Related Dementias (ADRD)

PROJECT SUMMARY
Alzheimer’s Disease (AD) and related dementias (ADRD) are recognized as major public health issues that are
projected to worsen in the aging U.S. population — the number of people of age 65 and older in the U.S. will
reach 88 million by 2050. However, despite intensive efforts, there is an absence of sufficiently effective
therapeutic options. Advanced glycation end products (AGE) formation is an established pathogenic factor in AD
progression, impacting both amyloid beta and tau. Brains are replete with glucose and ascorbate, both of which
are AGE precursors. AGE formation is initiated by the breakdown of glucose adducts on proteins via an oxidative
chemical reaction requiring redox metal ion catalysis, and it is known that AD progression leads to brain
accumulation of pro-oxidant copper and iron. These AGE accelerants generate toxic free radicals and reactive
oxygen species (ROS) that can independently cause neuronal damage. Our hypothesis is that a drug candidate
that: (1) is brain penetrant, (2) inhibits AGE formation, and (3) reduces oxidation by redox metal ions will exhibit
efficacy in treating AD/ADRD. We advance in this proposal the novel “Amadorin” drug candidate PTG-630, a
potent inhibitor of advanced glycation end products (AGEs) that also has the dual potential as an antioxidant due
to its binding of redox metal ions, particularly Cu2+. We previously discovered that PTG-630 prevents mild
cognitive impairment in diabetic rats and in a transgenic mouse model of AD when treatment was begun at onset
of disease. We now propose to evaluate the therapeutic potential of PTG-630 in reversing established cognitive
dysfunction and neurodegeneration in multiple animal models of AD, as this is the most likely scenario for clinical
use of a therapeutic agent.

Public health relevance
PROJECT NARRATIVE Alzheimer’s Disease (AD) is recognized as a major public health issue that is projected to worsen in the aging U.S. population — the number of people of age 65 and older in the U.S. will reach 88 million by 2050. There is an absence of sufficiently effective therapeutic drugs that can delay the onset or prevent disease progression. This would have enormous benefits, both to patients and to our economically burdened health systems. Based on our recent preclinical findings, Praetego intends to advance their novel drug candidate PTG-630 as a disease modifying therapeutic with potential to impact onset or progression of AD and its related dementia (AD/ADRD).